HIV-1 Integrase Interactions with Viral RNA

Abstract
HIV-1 integrase (IN) plays two essential roles in the virus life cycle: i) during early steps of infection, IN catalyzes
the covalent insertion of viral complementary DNA into target cell chromatin; ii) during late steps of viral
replication, IN binds to the viral RNA genome (vRNA) to yield properly mature, infectious virions. The structural
and mechanistic bases for IN catalytic activities have been characterized extensively, and the catalytic activity
of IN has been exploited as a therapeutic target. By contrast, the non-catalytic function of IN remains largely
underexplored. Initial mutational studies demonstrated that certain IN amino acid substitutions impair proper
virion maturation by mislocalazing ribonucleoprotein complexes (RNPs) outside of the protective capsid. This
phenotype has been termed class II IN substitutions to delineate them from class I IN mutations that specifically
impair the catalytic activity of the viral protein. More recent studies have discovered that IN binds vRNA in virions,
and that these interactions are essential for proper virion maturation. IN exhibits distinct preference for select
vRNA elements including the trans-activation response (TAR) element. Biochemical assays revealed that IN
tetramers rather than dimers or monomers effectively bind to cognate vRNA segments. Furthermore, mutational
studies have identified IN residues that selectively impaired IN-vRNA binding without substantially affecting other
functions of the protein. The non-catalytic function of IN during virion maturation is an important, yet clinically
unexploited, therapeutic target. A new and promising class of HIV-1 inhibitors called allosteric IN inhibitors or
ALLINIs potently impair IN-vRNA interactions in WT, but not escape mutant, virus. Consequently, ALLINI
treatments yield eccentric non-infectious virions with mislocalized RNPs that phenocopy the class II IN mutations.
Despite these remarkable advances, the critical gaps in knowledge remain. Specifically, structural and
mechanistic foundations for how IN preferentially binds select vRNA elements and encapsulates the vRNA
genome within the mature capsid are unknown. To begin addressing these important questions, we propose the
following two specific aims. In Aim 1, we will develop a highly innovative and powerful biochemical model system
for assembly of mature virus-like particles (mVLPs), which will examine the ability of recombinant IN to effectively
encapsulate vRNA inside capsid-like particles (CLPs). Furthermore, we will test whether class II IN mutations
and ALLINI treatments can prevent IN-mediated encapsulation of vRNA within CLPs. In Aim 2, we will determine
cryo-EM structures of IN tetramers bound to TAR RNA. Follow up biochemical and virology experiments will
validate our structural findings. Collectively, the proposed research will substantially advance our understanding
of the non-catalytic function of IN during virion morphogenesis and benefit the ongoing efforts to develop
improved ALLINIs for their clinical applications.

Public health relevance
Narrative Our research focuses on elucidating structural and mechanistic foundations for HIV-1 integrase interactions with the viral RNA genome, which is required for the formation of infectious virions. This non-catalytic function of HIV- 1 integrase is an important therapeutic target for a novel, investigational class of antiretrovirals called allosteric integrase inhibitors or ALLINIs.